Investigating the role of Yap/Taz in neural crest-derived cardiac development

Project Summary/Abstract
Congenital heart defects (CHDs) are the most common human birth defect. Although CHDs are highly
prevalent, knowledge regarding disease onset is currently limited, restricting therapeutic progression. CHDs
can arise due to the altered contribution of cardiac progenitor cell populations, including cardiac neural crest
cells (NCCs), a vital migratory and multipotent cell population for proper mammalian heart formation. The
fundamental Hippo signaling pathway is crucial in regulating heart development and homeostasis. Patient data
and animal models have indicated that changes in Hippo signaling result in various types of CHDs. The
canonical Hippo downstream effectors Yap and Taz are essential for NCC regulation throughout the developing
embryo, yet their role in NCC-derived heart development remains unknown. I maintain a mouse cohort with a
Cre recombinase conditional deletion of Yap/Taz in the NCC population and found that Yap/Taz deficiencies in
NCCs result in external and internal cardiac defects, creating a CHD mouse model. Furthermore, I identified
that deficiencies of Yap/Taz reduced cardiac outflow tract (OFT) cell migration capabilities ex vivo and in vitro.
This project aims to define how mutant Hippo signaling drives the dysregulation of NC and cardiac
development. I hypothesize that the Hippo signaling effectors Yap/Taz regulate proper cardiac remodeling
during NCC-derived heart development. Aim 1 will investigate the role of Yap/Taz in cardiac OFT development
by characterizing altered cellular composition due to Yap/Taz deficiencies and performing sc-multi-omics on
control and Yap/Taz deficient cardiac OFTs. Aim 2 will explore the mechanism underlying Hippo-regulated NCC
differentiation and its impact on cardiac tissue stiffness both in vivo and in vitro. This project will elucidate the
roles of Hippo signaling in NCC-derived heart development. Findings from these proposed studies will shed
light on the molecular mechanisms regulating heart development and help develop novel diagnostic and
therapeutic strategies for CHDs.

Public health relevance
Project Narrative The Hippo signaling pathway is fundamental for proper organ development, but little is known about its role in neural crest-derived heart development and how genetic mutations of the pathway contribute to congenital heart defects. The project aims to uncover how Yap/Taz, downstream effectors of Hippo signaling, regulate cardiac neural crest cell migration and differentiation using animal and cell models. This work will lead to an increased understanding of proper heart development and the identification of potential new therapeutic targets for treating and preventing congenital heart defects.